Increasing the isoplanatic patch in adaptive optics ophthalmoscopy

PROJECT SUMMARY
The optics of the eye suffer from imperfections (wavefront aberrations) that blur retinal images. This blur limits
our ability to diagnose eye disease before irreversible damage and vision loss take place. Adaptive optics (AO)
ophthalmoscopy can correct for this blur, which is unique to each eye and retinal location. Current AO
ophthalmoscopes can only capture images of very small retinal areas because they cannot correct for the
variation of the wavefront aberrations across the retina. This limitation impedes the use of this technology for
detecting early signs of disease, which in turn, enable the early treatment that would mitigate irreversible vision
loss. Here we propose to first measure how wavefront aberrations change across the retina in a human subject
population to improve the design and operation of all future AO ophthalmoscopes. We also propose two novel
methods for measuring and correcting wavefront aberrations that vary across the retina to increase the field of
view of these instruments. First, we propose to measure aberrations sequentially at various points in the field of
view and then deliver appropriate sequential wavefront corrections at each retinal location. This low-cost, low
complexity approach could be used to double the retinal coverage of current AO scanning ophthalmoscopes.
The second approach uses two wavefront correctors, the optimal axial positions of which will be determined by
using the data on wavefront aberration changes with retinal location and wavelength across the population. This
more complex approach aims to at least quadruple retinal coverage. The resulting increase in the field of view
will be a major step towards translating AO ophthalmoscopy into a practical clinical tool for improving the
diagnosis and treatment of eye diseases.

Public health relevance
PROJECT NARRATIVE We propose to develop technical advances necessary for increasing the field of view of adaptive optics ophthalmoscopes, in order to overcome a barrier for detecting the earliest signs of eye disease. This will in turn enable the early treatment necessary to mitigate irreversible but preventable vision loss in conditions for which treatments currently exist.